Development of FISH Molecular Diagnostics to support Clinical Trials at NCI

The FISH Lab in the Laboratory of Pathology is a valuable resource at CCR, NCI to support active NCI clinical protocols. The section provides clinical diagnostic service for CCR investigators with Fluorescence In Situ Hybridization (FISH) CLIA/CAP testing in support of Surgical Pathology diagnostics and testing patients for NCI clinical protocol eligibility. More importantly, the laboratory represents a bench-to-bedside bridge that keeps pace with the latest discoveries in biomedical research, bringing new discoveries to clinical patient testing more rapidly than would be available from reference laboratories. The FISH Lab currently supports 16 clinical trials at the NCI. That includes requests from the entire community of CCR investigators: Neuro-Oncology Branch, Thoracic & GI Malignancies Branch, Vaccine Branch, Pediatric Oncology Branch, Experimental Transplantation and Immunology Branch, Surgery Branch, Urologic Oncology Branch, Office of the Director. The active test menu includes FISH assays for clinically significant chromosomal translocations and amplification events in solid tumors and hematologic malignancies. The FISH Lab actively participates in research collaborations with other investigators within the CCR and other NIH Institutes to advance basic and clinical research.